Malassezia and Candida auris: skin microbiome dysbiosis and de-regulation of cutaneous homeostasis

Abstract Malassezia yeasts are lipophilic and are the most abundant fungi of the skin microbiome of warm-
blooded animals. In addition to a commensal lifestyle, Malassezia yeasts are associated with skin diseases
and also bloodstream infection. Studies have linked Malassezia in the GI tract as a risk factor for Crohn's
Disease in patients with CARD9 mutations and potentially in pancreatic cancer progression, whereas
Malassezia in the lung has been linked to Cystic Fibrosis exacerbation. In parallel, Candida auris has
emerged globally and is frequently drug-resistant and increasingly causing hospital-acquired skin
colonization with significant risk of systemic infection with significant morbidity and mortality. Julie Segre and
colleagues have developed a mouse model of Candida auris colonization and found that human skin
mycobiome dysbiosis, likely caused by antibiotics and antifungal drugs, shifts skin colonization from
Malassezia-dominant to Candida-species dominant patterns prior to Candida auris systemic infections.
Genetic and genomics studies from our group and others have advanced the state of the art for the study
of Malassezia species and their interactions with bacteria and fungi in the skin microbiome and the host. We
developed an Agrobacterium tumefaciens approach enabling generation of both random and targeted
mutants of two Malassezia species, and applied these tools to study functions of Malassezia genes with roles
in drug action and host-pathogen interactions. We have conducted extensive genomic analysis, contributing
genome annotation via proteomics and obtaining complete telomere-telomere, well-annotated Malassezia
reference genomes. Our past studies on Candida species defined a globally conserved role of calcineurin in
fungal pathogenesis, advanced genomics across the Candida pathogenic species complex, and documented
that Candida lusitaniae, closely related to Candida auris, has a complete sexual cycle. Our key collaborator
Salome LeibundGut-Landmann has developed a murine skin model for Malassezia integral to these studies.
Here we propose to study the interactions of Malassezia with Candida auris in dysbiosis of the skin
microbiome as a risk factor for systemic infection. In Aim 1 we propose to focus on 1) a novel dsRNA
Malassezia mycovirus we discovered and its encoded candidate protein effector by generating and studying
strains cured of either or both viral RNAs, and 2) Malassezia secreted proteins (including allergens and
proteases) by studying gene deletion mutants as well as random insertion mutants. In Aim 2, Malassezia
virus-infected, virus-semi-cured, and virus-cured strains and mutants generated in Aim 1 will be studied with
in vitro and in vivo models to define molecular mechanisms of interactions with Candida auris and the host.
The studies proposed will advance the field, providing insights as a foundation for studies aiming to elucidate
the beneficial roles Malassezia plays as skin commensals that protect the human host from systemic infection
by fungal pathogens through competitive and exclusive colonization of the skin microenvironment.

Public health relevance
Narrative Malassezia are lipid-dependent yeasts that are part of the normal commensal microbiome on human skin, and they are also associated with several skin diseases and implicated as playing a pathogenic role in Crohn's Disease, pancreatic cancer, and exacerbation of Cystic Fibrosis. In parallel, Candida auris has emerged globally as a human fungal pathogen that is frequently hospital-acquired and drug-resistant; this pathogen initially colonizes the skin and then causes systemic infections that are a significant cause of morbidity and mortality. This proposal aims to apply recently developed genomics and genetics resources (combined with models of host-pathogen and microbial interactions) to elucidate molecular mechanisms of Malassezia pathophysiology in dysbiosis of the skin microbiome as a risk factor for Candida auris colonization and infection and provide insights to advance diagnosis, treatment, and prevention approaches and thereby improve human health.